BCCMA: Targeting Gut-Microbiome in Veterans Deployment related Gastrointestinal and Liver diseases; CMA5- Functional metagenomics in GWI-related gut dysfunction

Gulf War Illness (GWI) is estimated to affect 25-32% of the over 700,000 coalition troops deployed to the
Persian Gulf as part of the First Gulf War. GWI causes a wide array of pain, fatigue, gastrointestinal, skin,
neurologic, and respiratory symptoms. Longitudinal studies have shown little to no overall improvement in
symptoms over time. There is thus a critical need to development new treatments to reduce GWI-associated
morbidity.
The role of the gut microbiome in overall health has been a focus in recent years. The gut microbiome plays
critical roles in metabolism and immunity. Gut microbiota ferment dietary fibers to product short-chain fatty
acids (SCFAs), which play roles in host energy production, appetite, and are thought to play important roles
in the gut-brain axis. SCFAs have also been shown to protect the gastrointestinal (GI) barrier from
proinflammatory cytokines. Preliminary research suggests that the gut microbiome and SCFAs may play a
role in GWI symptoms.
Our overall goal is to better understand the role that SCFAs and the microbiota involved in gut homeostasis
have in causing gut dysfunction and inflammation in Veterans with GWI – the critical next step in developing
potential treatment targets. Our central hypothesis is GWI Veterans experiencing gut dysfunction will have
lower abundances of SCFAs and their associated microbiota than those without gut symptoms and that
those consuming diets higher in dietary fiber will report fewer GI symptoms. We plan to evaluate this
hypothesis using both an existing, longitudinal cohort of 36 GWI Veterans and 33 controls as well as
enrolling a new cohort of 48 GWI Veterans with GI symptoms to investigate the following specific aims:
Aim 1: To assess the relationship between GWI, gut permeability, and the functional potential of the gut
microbiome in Veterans with and without GWI using whole metagenome sequencing of previously
collected stool specimens.
Aim 2: To examine the relationship between low-grade inflammation measured and the presence of
short-chain fatty acids and other predicted metabolites identified using the gut metagenomic data in
Veterans with GWI compared to those without GWI using pre-existing serum and stool samples.
Aim 3: Implementation of a resistant potato starch intervention to alleviate symptoms associated with
GWI and improve Veterans’ quality of life.
The proposed research is a direct continuation of pilot funding we received to assess the microbiomes of
Veterans with GWI. Through the proposed research, we will build on the GWI knowledge base through
developing a better understanding of the role of metabolites and the microbiota involved in gut homeostasis in
causing gut dysfunction and inflammation in GWI Veterans – the critical next step in developing potential
treatment targets. We will also conduct an intervention study to evaluate the role of a low-cost, low-risk dietary
fiber intervention (resistant potato starch prebiotic) in alleviating GWI-related symptoms, particularly GI
symptoms. The work proposed here has the potential to not only improve the lives of Veterans with GWI, but
may also help develop treatments for other combat and non-combat related functional GI diseases.

Public health relevance
Gulf War Illness (GWI) affects an estimated 25-32% of the over 700,000 coalition troops deployed to the Persian Gulf as part of the First Gulf War. GWI causes a range of pain, fatigue, gastrointestinal, skin, neurologic, and respiratory symptoms. New treatments to reduce GWI-associated morbidity are critically needed. Research suggests a role for the gastrointestinal microbiome in mediating health, including through impacting metabolism and immunity. The disruption of this microbiome plays a role in multiple diseases, and preliminary data suggest that Veterans with GWI have altered gut microbiota. Here, we will assess gut microbiome function and inflammation in Veterans with GWI who experience gastrointestinal symptoms. We will also evaluate the effectiveness of a dietary fiber prebiotic supplement intervention on improving the quality of life of Veterans with GWI. Together, these data will provide important insight into the underlying role of the gut microbiome in GWI and the potential for treatments targeting the microbiome to reduce GWI symptoms.